“Conus venom peptides and their molecular targets: Using pharmaconomics and neuroethology as a framework for discovery”

Project Summary/Abstract
The hundreds of different bioactive components in the venoms of cone snails have demonstrated
extraordinary biomedical potential in the past, including development as an FDA-approved drug. However,
their discovery and characterization is generally limited by the small amounts of venom that are accessible.
Our laboratory has developed a calcium-imaging platform combined with selective pharmacology
(“Constellation Pharmacology”), that when combined with recent technical advances in transcriptomic and
proteomic analysis and electrophysiology (an integrated platform that we call Pharmaconomics) completely
changes the landscape with respect to discovery and characterization of novel venom components. Using
pharmaconomics, one goal is to tightly couple the discovery and biochemical characterization of individual
venom components with the elucidation of the molecular and cellular mechanisms that underlie their biological
activity. The pharmaconomics approach also uncovers how individual components affect physiology at the
system’s and whole animal level. We will use the insights gained from the characterization of bioactive venom
components to rationalize the species-specific behavior and neuroethology of the cone snail and it’s fish prey.
These new tools should allow an unprecedented rate of discovery of novel bioactive cone snail venom
components tightly linked to the elucidation of their molecular targets.
Although the focus of this project is on venom peptides and their molecular targets, the
pharmaconomics approach can be used for elucidating the physiologically-relevant molecular target of any
natural product. Linking the vast chemical diversity of natural products to their cognate macromolecular
receptors should greatly expand the use of natural products as pharmacological tools in basic research, as well
as their therapeutic and other biomedical applications.

Public health relevance
Project Narrative A group of marine snails (Conus) have evolved complex venoms that allow them to catch fish; this project aims at understanding how the diverse venom components act to change the physiology of fish and other vertebrates, including humans. Because each individual component of the venom acts like a drug,these individual venom compounds have great biomedical potential; one has become an approved drug for pain, and two others reached human clinical trials (for epilepsy and spinal cord injury pain). By greatly increasing the number of defined venom components, and having insight into how each acts, many more therapeutic and diagnostic uses should emerge.